Environmental determinants of human sleep timing, duration and continuity: studies in hunter gatherers

Abstract
Many health disorders have been attributed to the changes brought about by “modern” civilization.
Understanding how the changes in the modern environment are affecting health requires comparison with
humans living in the pre-modern environment. The number of groups living in the traditional way is rapidly
diminishing. Electrification and the economic development of Native American reservations eliminated such
groups in the US decades ago. A similar process is ongoing in other regions of the world. Only a few groups of
hunter-gatherers remain. We began a study of sleep in non-industrial humans to test the widespread belief that
“modern” humans sleep much less than the evolved “natural” amount. We found that, surprisingly, at the time
points that we sampled, sleep durations in all three groups we studied were lower than those seen in most
studies of industrial societies. Furthermore, we found a nearly 1 hour difference between summer and winter
sleep durations in the two groups we sampled for 1 week periods in both seasons, settling the longstanding
controversy over whether human sleep durations respond to seasonal changes. The prior consensus was that
there was no difference or only a minor change in duration. We also found that, unlike other primates, humans
in the natural environment do not typically start sleep at sunset nor do they awaken at sunrise. Rather, sleep
onset is several hours after sunset and awakening is 30-60 minutes before sunrise. At the time points
examined, our preliminary studies suggest that hunter-gatherers do not show peripheral vasodilation at sleep
onset. But, they peripherally vasoconstrict upon awakening. In contrast, laboratory studies show that “modern”
humans have the opposite pattern, peripherally vasodilating at sleep onset but not peripherally
vasoconstricting upon awakening. Most strikingly, hunter-gatherers do not report or exhibit substantial levels of
insomnia, with rates under 2%, in comparison to the 10-15% rates reported in all industrial societies. Our data
suggest that environmental temperature and the thermoregulatory responses to the daily temperature cycle
may be as important, or more important, than light level in the physiological regulation, function and pathology
of human sleep. Nearly all studies of the timing of human and animal sleep have been conducted at constant,
thermoneutral temperatures and have focused on the role of electric light. We propose to record sleep and
core, peripheral and ambient temperature as well as ambient light levels under natural, evolutionarily relevant
conditions by monitoring subjects continuously across an entire year. Our integrated approach will allow us to
compare the effect of light and temperature on sleep time, EEG defined sleep states and alertness. These will
be the first such studies under natural conditions and will provide insights into the temperature and light
parameters differentially linked to REM vs nonREM sleep, EEG spectra, sleep duration, sleep continuity and
daytime alertness in humans. This data may explain the virtual absence of insomnia in hunter-gatherers, its
ubiquity in industrialized societies, and suggest treatments to reverse this disorder.

Public health relevance
Narrative It has been suggested that a return to the natural sleep pattern would have enormous health benefits, but it is not clear what this natural pattern is. Because hunter-gatherer groups are rapidly, and in some cases forcibly, being integrated into our modern culture, the opportunity to gain this fundamental insight into human behavior will soon vanish forever. Our goal is to understand the cause of pathologies in “modern” sleep timing and continuity by studying the temperature and light determinants of sleep and alertness in hunter gatherers, raised from birth in the natural environment, whose rate of insomnia is about a tenth of the modern rate, and whose overall health, taking into account the health risks of the hunter-gatherer environment, is much better than that of industrial societies.